FAT FREE MASS, LOW CALORIE DIET IN OBESITY AND DIFFERENT BODY COMPOSITION

Difference, if any, in protein loss and fat free mass loss between moderately obese and severely obese subjects when they are on the same calorie restriction.